Center for Gastrointestinal Biology and Disease

PROJECT SUMMARY
The burden of digestive and liver diseases in the US exceeds $119.6 billion. The overall principle that
guides the Center for Gastrointestinal Biology and Disease (CGIBD) is that improvement in the lives of
patients with digestive and liver disease will be accelerated by multidisciplinary research on
gastrointestinal biology that can be rapidly translated into new therapies. The overall mission is to
promote and enhance multidisciplinary research on various aspects of clinically relevant
gastrointestinal biology, pathophysiology, and epidemiology to reduce the burden of digestive disease.
The Center achieves this mission through the following specific aims:1) Foster cutting-edge research
by maintaining core facilities that provide new technologies, expertise, training, technical assistance,
laboratory animals, biostatistical and clinical research support. 2) Accelerate digestive disease
discovery by offering pilot/feasibility funds to promising investigators; 95% of whom have received
research funding following their P/F during the past 10 years. The P/F program also serves as an
incubator – 71% of current members have received a P/F award. 3) Promote multi-disciplinary
collaborative investigation through a scientific enrichment program. 4) Advance the careers of junior
faculty and trainees through professional development and training activities. Members include 46
full and 10 associate members from 24 departments in 3 universities located in the Research Triangle
of North Carolina. The annual direct costs for digestive disease-related grants to members total $29.2
million with 48.1% from NIDDK and 33.1% from other NIH institutes. Of the 56 members, 52% have
one or more current research grants from NIDDK. The overarching theme for the Center is
Bioresilience, a theme that encompasses the wide range of research conducted by the membership.
Within the theme, members cluster into three program areas: microbiome, clinical/translational
research, and regeneration and repair. To support the research of members, the Center proposes an
Administrative Core and the following scientific cores: 1) Advanced Analytics; 2) Clinical Research; 3)
Gnotobiotic Animal; 4) Large Animal Models. These cores have evolved to support the scientific
directions of center members and to provide new investigative opportunities. The cores improve
efficiency, lower cost, and provide services that would not otherwise be available to
investigators. During the past 5 years, 95% of members wrote papers with 2 or more CGIBD
members as authors. Through all its activities, the Center improves communication, promotes
collaboration, develops careers, and generally enriches the environment for digestive disease
research to lead to critical scientific advances.

Public health relevance
PROJECT NARRATIVE The annual burden of digestive diseases is considerable, exceeding $119.6 billion. The Center for Gastrointestinal Biology and Disease promotes multidisciplinary research to improve the understanding of the biology, physiology and epidemiology of digestive diseases. The expectation is that this knowledge will be translated into new strategies for prevention and treatment that will lower the burden of digestive diseases.